Mapping, programming, and correcting gene regulatory sequences for Alagille Syndrome

PROJECT SUMMARY
Regulatory DNA elements, including enhancers and promoters, encode multiple transcription factor binding sites
(TFBS) that quantitatively tune gene expression in a cell-type specific fashion. Understanding and engineering
regulatory DNA could unlock new therapeutic approaches — for example, to restore proper expression of a
disease gene.
Diseases of haploinsufficiency, such as Alagille Syndrome, are one example where such an approach could be
transformative. Alagille Syndrome involves haploinsufficiency of JAG1, where improper dosage in vascular
endothelial cells and smooth muscle cells leads to life-threatening complications including biliary atresia as well
as right-sided congenital heart defects. An ideal gene therapy solution for Alagille Syndrome would be to
engineer the promoter of JAG1 to turn up the production of the unaffected allele of the gene by 2-fold. Yet, our
knowledge of how to program regulatory DNA to control gene expression is incomplete, in large part because
we have lacked tools to accurately identify, edit, or characterize TFBS in regulatory elements in the genome.
Our team has now developed innovative tools to dramatically increase the throughput of characterizing both
endogenous and synthetic TFBS and their effects on gene expression in the context of Alagille
Syndrome — allowing us to design DNA edits, test their impact on gene expression with high-throughput
screens, and evaluate their ability to correct pathological patterns of gene expression. In Aim 1, we will build a
genome-wide nucleotide-resolution map of TFBS in endothelial cells and smooth muscle cells from healthy and
Alagille hiPSCs in conditions of static, physiologic, and pathological flow. In Aim 2, we will apply new pooled
prime editing technologies to systematically mutate regulatory DNA sequences in the JAG1 promoter and identify
TFBS that can increase JAG1 gene expression. In Aim 3, we will use CRISPR to correct JAG1 expression in
hiPSCs from Alagille patients and characterize their effects on gene expression and cellular phenotypes.
Together, these studies will illuminate basic mechanisms of Alagille Syndrome, test whether restoration of JAG1
function in cells from Alagille patients is sufficient to correct disease-associated cellular phenotypes, and
demonstrate a new strategy to program gene expression in the human genome by combining nucleotide-
resolution computational modeling with high-throughput sequence editing of endogenous gene promoters. This
approach is generalizable and can be applied to other diseases where programming gene expression is
desirable, such as for other haploinsufficiencies.

Public health relevance
PROJECT NARRATIVE This proposal aims to understand how regulatory DNA sequences quantitatively tune gene expression in specific cell types and/or disease contexts, and how we can engineer these sequences to reprogram gene expression to restore function in the context of Alagille Syndrome. Our approach combines reading and writing of the genome in human pluripotent stem cells that can be used to model the functions of cells from human blood vessels. Our study will lay the foundations for future studies to develop CRISPR therapeutics for Alagille Syndrome and other diseases.